Cancer Research Training and Education Coordination

Education and training have been central to the mission of the Abramson Cancer Center (ACC) throughout its existence. The ACC Cancer Research Training and Education Coordination (CRTEC) component coordinates ACC cancer-related education, training, and career activities. In this role, CRTEC integrates these activities across the Penn campus, including the ACC, the Perelman School of Medicine (PSOM), and nine other Penn Schools that have activities with cancer education and training content. A prime focus of CRTEC is to drive and promote cancer education and training activities in the ACC and across the University of Pennsylvania with the goals of delivering cancer-related education to students, trainees, faculty, and other professionals and expanding the cancer workforce through targeted education, training, and mentorship. The Specific Aims of CRTEC are as follows: Aim 1: Coordinate cancer education, training, and career development activities across the ACC and Penn; Aim 2: Provide cancer research-related education, training, and mentorship to individuals ranging from high school and undergraduate students to cancer professionals, with an emphasis on ensuring an enduring pipeline of trainees and future cancer researchers; and Aim 3: Evaluate the quality and impact of ACC CRTEC activities to improve ACC education/training and to guide new CRTEC developments. CRTEC impacts students, trainees, and professionals with a goal to advance cancer research careers starting with entry-level professional training through faculty and cancer research leadership roles. CRTEC is led by an ACC Associate Director for Education and Training, senior support staff, and an Operations Committee. It interacts with the Programs, Shared Resources, and Community Outreach and Engagement. CRTEC impacts the ACC by (1) coordinating the already varied, well-established, and extensive cancer-related education and training activities at the ACC and Penn; (2) improving access to cancer-related education for students, trainees, staff, and professionals; (3) sustaining cancer career development through integrated cancer-related training and mentoring for faculty, trainees, and staff; and (4) enhancing representation at all levels of education and training. CRTEC leverages formidable strengths at ACC and Penn in cancer education and training that include a compact, accessible, and highly integrated campus with extraordinary depth in all disciplines relevant to cancer research; longstanding cancer-focused education in the ACC, PSOM and other Schools; a uniquely large and heterogeneous portfolio of GME and biomedical postdoctoral training programs, many with decades of NCI and other funding; extensive ACC-directed professional education; and expertise and national leadership in basic, translational, clinical, and population-based cancer research. CRTEC provides ACC members with a central point of contact for innovations in cancer-related education and training.